Protein-protein interactions and structural switching of the bifunctional Chlamydia trachomatis protein, Scc4

PROJECT SUMMARY
The role of the bi-functional Chlamydia trachomatis protein, Scc4 (formerly Ct663), in regulating the type III se-
cretion system (T3SS) and the essential, developmental cycle (between infectious elementary bodies and ac-
tively dividing, reticulate bodies) is not well-understood at the molecular level. Scc4 is a unique protein that
functions (i) as a T3SS chaperone with Scc1 to regulate secretion of CopN (an essential virulence factor) and
(ii) as a transcription factor regulating 66-RNA polymerase holoenzyme. Based on progress made during the
last funding period, the switching mechanism proposed for Scc4’s dual functions involves a conformational
change in its 3-dimensional structure. Because Scc4 has two essential functions and is unique to C. tracho-
matis, it is a novel target for developing anti-virulence drugs. To develop drugs targeting the C. trachomatis
T3SS and developmental cycle, hit-compounds must first be identified and their effects on Scc4’s structure,
protein-protein interactions, and functions characterized. The long-term goal of the proposed research is to de-
velop drugs targeting Scc4’s functions, which would prevent the bacteria from spreading, likely curing C. tra-
chomatis directly and certainly mitigating the development of antibiotic-resistant strains, when combined with
current therapies. The overall objectives of this application are to increase our understanding of the conforma-
tional changes and binding sites that regulate Scc4’s switching mechanism and protein-protein interactions.
The central hypothesis is that a conformational switch in Scc4’s structure, induced by binding native ligands,
regulates its dual activity. The rationale for the proposed research is that inhibitors to disrupt Scc4’s functions
can be rationally designed, resulting in new approaches to treat C. trachomatis and new molecular tools to
study the T3SS and developmental cycle. The central hypothesis and objectives of this application will be
tested and attained by pursuing two specific aims: (1) identify small molecule ligands that bind or disrupt Scc4
and its T3SS complexes and (2) map the native protein- and small molecule-ligand binding sites on Scc4 and
Scc4:Scc1 and identify allosteric effects. It is anticipated that these aims will yield the expected outcome of a
structural model of ligand-binding sites on Scc4 and the Scc4:Scc1 complex from native ligands and hit-com-
pounds. This outcome is expected to have an important positive impact because characterization of the protein
binding sites and identification of small molecule ligands provide the information necessary to develop drugs
targeting Scc4’s conformational switch or protein-protein interactions, fundamentally advancing the fields of
structural biology and infectious disease biology. This contribution is significant because it is the first step in a
continuum of research that is expected to lead to understanding Scc4’s dual functions at the atomic level and
contribute to the treatment of the most common, sexually transmitted bacterial disease. The proposed research
is innovative because the NMR structural and biochemical characterization of a unique bi-functional protein
from C. trachomatis to target bacterial virulence as a therapeutic strategy represents a new and substantive
departure from the status quo.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because Chlamydia trachomatis is the most common, sexually transmitted bacterial disease in the United States and can cause reproductive health complications and pneumonia in infants born to infected women. A novel enzyme of Chlamydia trachomatis, called Scc4, is an attractive drug target because it has two functions that contribute to the pathogenesis of this disease. Screening compounds and native ligands is an essential step toward the rational design of drugs and to provide molecular tools to fundamentally advance the field of microbiology.